Taurine, an endogenously produced semi-essential micronutrient, as a regulator of lifespan and healthspan

Summary
The age-induced decline in organ functions involves multiple cell intrinsic events. However, and since most
physiological processes are orchestrated by extracellular environment, aging is also a consequence of
progressive breakdown of extracellular milieu which proffers potential targets for anti-aging therapeutics. Taurine
is a semi-essential micronutrient found in organisms across eukaryotic phyla. In mammalian cells, taurine is
produced from cysteine by the action of cysteine sulfinate decarboxylase (Csad) and performs a variety of
important functions. Taurine can also be obtained from extrinsic sources through a transporter (Slc6a6). Taurine
supplementation to young wild-type mice improves, while congenital taurine deficiency due to the lack of
SLC6A6, in humans and in mice, impairs functions of multiple organ systems known to be affected during aging.
These evidences suggest that taurine may regulate processes associated with aging; however, the effect of
taurine on healthspan and lifespan in aged animals, developmental versus postnatal origin, and the underlying
mechanisms are unknown. Our preliminary results show that circulating and tissue levels of taurine decline with
age in mice, monkeys, and humans. This led us to hypothesize that taurine deficiency is a driver of normative
aging. Consistent with this hypothesis, once-daily oral administration of taurine to middle-aged WT mice
significantly increases, without any noticeable side effects, in both females and males, the lifespan by 12% and
10%, respectively, and suppresses morbidity. The lifespan extending effect of taurine was also observed in
worms suggesting that the effect of taurine transcends the eukaryotic evolutionary landscape to invertebrates.
An unbiased association analysis of taurine levels with clinical variables in aged-humans shows that taurine
levels associate with several degenerative diseases; and importantly physical exercise, which is known for its
anti-aging effects, increases taurine levels in humans. Illustrating the biomedical relevance of above findings,
daily oral feeding of taurine to aged-monkeys for 6 months significantly enhanced the functions of several organs.
Mechanistically, we find that taurine regulation of healthy lifespan is associated with changes in hallmarks of
aging, including a reduction in cellular senescence, increase in autophagy and proteostasis, suppression of
mitochondrial dysfunction, and attenuation of inflammaging. In Aim 1, we will determine the degree to which
short-term taurine supplementation at mid-life affects aging hallmarks and extends healthy lifespan through
transient (3-, 6- or 12-month) and life-long taurine supplementation. In Aim 2, we will determine the effect of
developmental versus postnatal taurine deficiency in regulating aging hallmarks, and healthy lifespan through
inducible conditional ablation of Slc6a6. In Aim 3, we will begin to identify the contribution of aging hallmarks and
upstream mechanisms through which taurine regulates healthy lifespan. Together, our studies are significant as
they will establish taurine deficiency as a driver of aging, elucidate its developmental versus postnatal effects,
and will identify the mechanisms through which taurine regulates normative aging.

Public health relevance
Narrative The overall goal of this proposal is to improve our understanding of the genetic and molecular control of normative aging by identifying a novel regulator, elucidating its modes of action, and documenting its therapeutic importance in suppressing morbidity and enhancing lifespan.